Pandemic Acceptance and Commitment Therapy (Pan-ACT): Feasibility and Acceptability of Telehealth Delivery with Older Veterans

Significance: Accounting for over 80% of COVID-19 related deaths in the United States, adults ages 65 and
older have been disproportionately impacted by this pandemic more than any other age group. As a result,
they may bear a heavy psychological burden in the months and years to come. Older adults have been labeled
“vulnerable” to COVID-19 and strongly encouraged to adhere to “social distancing.” This prevention measure is
meant to mitigate the spread of the virus but has increased older adults’ risk of social isolation and loneliness,
which are two known correlates of increased morbidity and mortality in late life. Pandemic-related restrictions
have decreased older adults’ life-space mobility and negatively affected their physical and nutritional well-
being, impairing their quality of life and potentially increasing their vulnerability to poorer outcomes if exposed
to COVID-19. Research has documented a plethora of pandemic-related stressors that are common among
older adults (e.g., fear of infection, loss of loved ones, financial repercussions) and the culminating
psychological impact. Telehealth-adapted evidence-based psychological interventions are needed to address
the psychosocial and physical toll of the pandemic among older Veterans. Acceptance and Commitment
Therapy (ACT) decreases emotional suffering, improves well-being, promotes and supports healthy behavior
changes, and treats a wide range of diagnoses by increasing psychological flexibility through mindfulness,
acceptance, and values-based behaviors. Higher psychological flexibility has been associated with pandemic-
related coping and well-being. Randomized studies of ACT with older adults are few but promising, and most
research studies with this population have used a group format. While research on telehealth delivery of ACT
for older adults is limited, preliminary results indicate it is feasible and as effective as ACT delivered in person.
Specific Aim: The proposed study will pilot a 10-session telehealth Pandemic ACT group intervention (i.e.,
Pan-ACT group) with Veterans ages 65 and older who are experiencing pandemic-related emotional and
physical distress.
Methods and Procedures: Twenty-five older Veterans will be enrolled in this single-arm feasibility pilot trial.
The intervention will be delivered weekly in 90-minute sessions of groups of {four} to five Veterans. {Feasibility
and acceptability of study procedures will be measured by referred-to-enrolled rate, telehealth access and
capability, electronic data collection of outcome measures, and qualitative feedback on data collection
procedures and measures. Feasibility and acceptability of the intervention will be measured by attendance;
attrition; homework completion; participant ratings of the intervention’s feasibility, acceptability, and fit;
qualitative feedback; and treatment fidelity.} Preliminary responsiveness of outcomes measures will be
explored. Participants will complete measures of pandemic-related emotional and physical distress,
psychological flexibility, depression, anxiety, social connectedness, perceived health, {functional impairment},
and meaningful engagement {at baseline, posttreatment, and one-month follow-up. A brief midpoint
assessment at week 5 of the group will consist of measures of social connectedness and functional
impairment. Qualitative data will be gathered on perceived efficacy to implement intervention skills and specific
emotional or behavioral changes participants have noticed in themselves as a result of the intervention.}
Conclusion: {This proposal directly aligns with the RR&D RFA to examine COVID-19-specific rehabilitation
interventions. The telehealth Pan-ACT Group is a mental and behavioral health rehabilitation intervention that
focuses on helping older Veterans develop or recover coping skills that were lost or are no longer effective
during the ongoing COVID-19 pandemic.} The proposed study leverages the investigators’ strengths and
expertise to address a major research and clinical gap, gather new knowledge for an urgent need, and inform
the development of a full-scale randomized controlled trial to evaluate the intervention’s effectiveness.

Public health relevance
Older adults have been disproportionately impacted and distressed by the COVID-19 pandemic. Social distancing and stay-at-home orders have increased older adults’ risk of social isolation and loneliness that will has led to a pandemic-induced fear of being in close proximity to other people. These fears and avoidant behaviors will have lasting effects if not treated with effective, safe, and convenient psychological interventions. This study will evaluate the acceptability and feasibility of delivering a small group intervention, called Acceptance and Commitment Therapy (ACT), through a telehealth modality to Veterans ages 65 and older who are experiencing pandemic-related emotional and physical distress. ACT helps decrease emotional suffering, improve well-being and promote positive behavior change by increasing one’s psychological flexibility through the practice of mindfulness, acceptance, and values-based behaviors. The knowledge gained from this study will be used to better tailor the invention to meet the needs of older Veterans in an era of post-pandemic recovery.